beta-Arylation of carbonyl compounds via C-H activation

DESCRIPTION (provided by applicant): One of the major challenges facing synthetic chemists is the design of novel and efficient methods for the functionalization of simple organic substrates. When a synthetic sequence can be rendered shorter, it enables the production of a greater variety of molecules by medicinal chemists in a more rapid timeframe. The net effect is that the drug discovery process becomes both cheaper and faster. This proposal describes a method for the enantioselective, direct beta-arylation of simple carbonyl compounds using ruthenium(ll) catalysts and readily available aryl halides. The proposed reaction has the potential to replace traditional synthetic approaches to this class of compounds which typically involve multi-step sequences that require the use of stoichiometric oxidants as well as organometallic reagents. The proposed transformation proceeds via initial activation of a beta sp3 C-H bond in a carbonyl compound by a ruthenium(ll) catalyst to form a metallacycle intermediate. Subsequent oxidative addition of an aryl halide followed by C-C bond-forming reductive elimination would then yield the arylated product. It is anticipated that the use of ruthenium(ll) as a catalyst will allow for the inclusion of ancillary ligands on the metal center which can control the chemo-, regio- and stereoselectivity of the transformation. The study would begin by investigating the stoichiometric activation of methyl C-H bonds by Ru(ll) pincer complexes, and subsequently examining the reaction of the isolated metallacycles with aryl halides. Conditions that render the overall process catalytic would then be identified and the scope of the reaction surveyed. By careful modification of the ligands, the more challenging functionalization of methylene C-H bonds would be investigated. Following preliminary mechanistic studies, an enantioselective version of the proposed reaction would then be developed by employing chiral pincer ligands. PUBLIC HEALTH RELEVANCE: The development of novel chemical transformations that proceed with high efficiency is essential to streamlining the process of drug discovery, which in turn is critical for improving public health. This application proposes a new method for the synthesis of an important class of organic molecules, which would be significantly more efficient than existing methods and would lead to shorter synthetic sequences.